THE SYNTHESIS AND PRECLINICAL STUDIES OF NEW TREATMENTS FOR NEURODEGENERATIVE DISEASE, DIABETES MELLITUS, CONGESTIVE HEART FAILURE, ONCOLOGIC AND IMMUNOLOGIC DISEASES

This is a general contract to support interactions between NIA staff and those of SRI in relation to: 1. Participation in regular teleconferences with the Contracting Officer’s Technical Representative (COTR) as well as internal SRI project meetings to discuss overall contract implementation and progress; 2. Preparation and submission of Monthly Technical Progress Reports and Annual Progress Reports as required by the base contract; 3. Provision of nonclinical/preclinical development consultation services to the COTR and NIA Submitting Investigators on future and to-be-assigned studies, including literature research to determine specific study requirements and scope. These activities usually include iterative discussions and provision of written preliminary study outlines to the COTR and Submitting Investigator to define specific study needs; and 4. Retention costs of archived GLP-regulated studies.